Utilizing Receptor-defined Odor Coding Channels to Understand Inhibitory Circuit Organization

Project Summary
Understanding how sensory receptors respond to a range of stimuli is essential for delineating how sensory
information is encoded, but neuronal response features are not determined solely by the interaction between
stimuli and receptors. Inhibitory circuits play a fundamental role in shaping response features to sensory stimuli,
therefore impacting the information that is relayed to higher levels of processing. Within the olfactory system,
responses are influenced by a diversity of inhibitory circuits but we still lack an understanding of the functional
organization of these circuits. Are inhibitory connections randomly organized or is there structure that reflects
receptor domains and chemical space? It remains challenging to map responses from the receptor level to their
principal output neurons and quantify inhibitory responses of the same neurons across individuals. The proposed
project overcomes this challenge by taking advantage of three receptor-tagged mouse lines to delineate how
inhibition is functionally organized in the olfactory bulb and how inhibitory responses manifest in postsynaptic
neurons. In Aim 1, I will test alternate models of lateral inhibitory organization and ask how inhibition is organized
relative to existing structure in the olfactory bulb. While it is known that lateral inhibition is odor-defined and
selective, little is known regarding how this selectivity is organized within and across individuals. In Aim 2, I will
then ask how inhibition manifests in postsynaptic cells that transmit sensory information to cortical regions.
Previous work suggests that the two types of postsynaptic output neurons in the olfactory bulb are differentially
influenced by inhibition, but there is conflicting evidence regarding whether sister cells receiving the same
receptor-defined inputs are homogenously modulated by inhibition. To test these questions, I will characterize
pre- and postsynaptic excitatory and suppressive tuning in vivo using olfactory receptor-defined neurons and the
most up-to-date optical reporters to image neuronal responses in awake, head-fixed mice. I will also image from
the soma of postsynaptic olfactory receptor-defined neurons by using a diagnostic ligand. This project will identify
novel principles underlying inhibitory circuit organization, which has implications for sensory processing across
modalities and will broaden our insight into the relationship between sensory receptors, stimulus identity, and
the organization of sensory circuits.
The proposed project will provide me with training in the technical skills and conceptual knowledge
needed for my future career goal of becoming a tenure-track researcher investigating how developmental
deviations impact the evolution and function of chemosensory systems. This research will take place in my
sponsor’s lab at the University of Utah, but I will spend a month in Spring 2025 in my co-sponsor’s lab at Duke
University learning in vitro techniques to assay odorant receptor activation. Both institutions have collaborative
research environments that will provide me with the necessary resources to complete my research training goals.

Public health relevance
Project Narrative Deciphering how the brain processes sensory information hinges on understanding how sensory receptors respond to a range of stimuli, but inhibitory circuits downstream of receptor-ligand interactions shape neuronal response features that are transmitted to higher-order regions of processing. This project will systematically test how inhibitory circuits are functionally organized in the olfactory bulb and how inhibition manifests in postsynaptic cells by leveraging the unique circuitry of the olfactory bulb, olfactory receptor-defined odor coding channels, and in vivo neuronal imaging. The results of this project will provide insight into fundamental principles of sensory processing and may translate to other sensory modalities, accelerating the ability to understand and treat sensory impairments.